The National Center for Interventional Biophotonic Technologies (NCIBT)

PROJECT SUMMARY – Overall
The long-term goal of the National Center for Interventional Biophotonic Technologies (NCIBT) is to promote
public health by advancing a new paradigm for intraprocedural, image-guided decision making. The Center's
strategy is to advance optical spectroscopy and imaging technologies, to develop means of providing imaging
results to medical practitioners at the time, in the form, and within the context they will be most useful in guiding
decisions, and to maximize the impact of this work by involving as many scientists and physicians as possible in
developing and using these technologies. Initially, the Center will promote technological advancements of
interventional fluorescence lifetime imaging (iFLIM) and interferometric diffuse optical spectroscopy (iDOS) and
their translation into clinical use. An open-ended intraprocedural platform will incorporate them and, eventually,
complementary optical imaging technologies. Specifically, NCIBT will (1) advance scalable optical imaging
technology, built from the perspective of intelligent optical system design, to characterize tissue properties in the
most effective manner; (2) develop an intraprocedural platform that physically incorporates these technologies
and integrates the resulting imaging data, details of the procedure, and patient-specific information within AI-
based decision algorithms that guide, in real-time, therapeutic decisions, and (3) disseminate these technological
advancements to research institutions and medical centers. The significance of this project derives from its
potential for rapid advancement, catalyzed by an AI-directed holistic approach to instrument design, of its optical
imaging technologies and platform and their relevance to managing humanity's most common afflictions - cancer,
stroke, heart disease, trauma, infection, and degenerative diseases. NCIBT will ensure the national impact of
these technological advancements by creating and expanding a network of collaborative research and service
projects broadly distributed nationwide and implementing a comprehensive training and dissemination program.
Annual workshops, hand-on training sessions at national meetings, in special courses and at UC Davis,
presentations and publications will educate, train, equip and diversify potential users of NCIBT technology.
Bridging gaps between engineering and medicine and between technology development and clinical application
will ensure that the needed technologies are developed and applied clinically to improve the nation's health.

Public health relevance
PROJECT NARRATIVE - Overall The National Center for Interventional Biophotonic Technologies (NCIBT) will promote public health by improving the clinical management of a broad range of common human conditions, including cancer, stroke, heart disease, high risk pregnancy, and dementia. Its advanced optical imaging devices will better characterize tissue structure and function and its AI-based analytical intraprocedural platform will integrate these imaging data and other patient-specific information into algorithms guiding treatment decisions. The availability of such helpful guidance as procedures are being performed or critical decisions are being made should help physicians make better choices that lead to improved patient outcomes.